Effects of maternal e-cigarette aerosol exposure on nicotine's addiction-related behavioral and neurobiological effects in offspring

SUMMARY/ABSTRACT
The goal of this project is to use animal models to understand how maternal exposure to electronic nicotine
delivery system (ENDS) aerosols during pregnancy adversely impacts addiction-related behaviors and
reinforcement-related neurocircuitry in offspring. An increasing number (up to 15%) of pregnant women are
using ENDS, exposing several hundred thousand fetuses per year in the U.S. alone. Combustible cigarettes
have long-term developmental consequences in offspring including increased risk of impulsivity-related disorders
such as attention deficit hyperactivity disorder (ADHD) and addiction to tobacco. These adverse effects are
generally attributable to nicotine, but other toxicants in tobacco smoke may also play a role. Although ENDS
contain lower levels of many of those toxicants, ENDS can deliver as much or more nicotine as combustible
cigarettes, and contain additional chemicals (e.g., propylene glycol, ethanol, unique flavorants, toxic byproducts)
that are not present in tobacco or tobacco smoke. Thus, ENDS use may pose not only many of the same risks
to pregnant women and their children as smoking, but unique risks as well. These issues have received only
limited attention, leaving the adverse effects of ENDS use during pregnancy largely unknown. Research to date
shows that prenatal ENDS exposure in rodents has adverse effects on several behavioral and genetic outcomes
in offspring that are attributable to nicotine and/or non-nicotine constituents in ENDS. However, no studies have
examined other potential adverse outcomes, such as increased impulsivity or abuse liability of nicotine and
associated adaptations in reinforcement-related circuitry. To address this issue, this project will examine the
effects of maternal inhalational exposure to commercial ENDS aerosols (fruit- and tobacco-flavor) on these
outcomes in rat offspring. Endpoints will include measures of impulsive action and impulsive choice (Aim 1),
nicotine abuse liability in nicotine self-administration models (Aim 2), and function of reinforcement-related
neurocircuitry following acute or chronic nicotine in intracranial self-stimulation models (Aim 3). Cell-specific
changes in gene expression and chromatin accessibility, as well as degree of nAChR upregulation, in key
reinforcement-related mesocorticolimbic areas (NAc, PFC), will also be analyzed to examine potential
neurobiological mechanisms mediating behavioral effects in these and other studies and generate hypotheses
for future studies (Aim 4). Inclusion of nicotine-free ENDS aerosol and aerosolized nicotine alone will allow us to
assess the relative contribution of nicotine versus other constituents in the effects of nicotine-containing ENDS
aerosol. Given the ability of certain non-nicotine constituents in ENDS aerosol to enhance the effects of nicotine
or produce adverse prenatal effects of their own, our overall hypothesis is that prenatal exposure to nicotine-
containing ENDS aerosol will produce greater adverse effects than the other exposure conditions. Findings will
provide new information to the public and the FDA on the potential risks of ENDS use during pregnancy and
suggest neural mechanisms of interest for future preclinical studies and brain imaging studies in humans.

Public health relevance
PROJECT NARRATIVE Use of electronic nicotine delivery systems (ENDS) among pregnant women is increasing, yet the adverse effects of ENDS use during pregnancy are largely unknown. This project will provide important data on the potential risk for addiction-related behavioral, neurobiological and genetic changes in offspring of mothers who use ENDS during pregnancy. Findings will inform clinical guidelines and public policy about ENDS use during pregnancy.